Role of alcohol adapted Kupffer cells in the progression and resolution of ALD

PROJECT SUMMARY
Alcohol-associated liver disease (ALD) is a major world-wide health problem that accounts for
approximately 40,000 deaths per year in the US. A major cause of death in ALD is the onset of an acute
liver failure event called alcohol-associated hepatitis (AH). The mechanisms that cause the onset of AH
in patients with ALD are unknown. The most important treatment for ALD is alcohol abstinence.
Unfortunately, some people with ALD who stop drinking fail to adequately improve in terms of liver
function or fibrosis. Again, the mechanisms leading to incomplete disease resolution after abstinence
are unknown. Liver macrophages, including Kupffer cells and infiltrating macrophages, play a central
role in regulating liver function during ALD but how they contribute to the onset of AH and what role
they play in the outcome of liver disease following alcohol abstinence is unknown. We recently
developed a new western diet alcohol (WDA) model of ALD that reproduces features of human alcohol-
associated steatohepatitis in mice. Using single cell RNA sequencing, we have identified alcohol
specific Kupffer cell subsets and assessed the function of these by selectively ablating them using
diphtheria toxin receptor techniques. During alcohol exposure, KC ablation resulted in liver failure with
hepatocytes de-differentiating into a progenitor-like phenotype very similar to the situation in human
AH. This result demonstrates that KCs play a previously unrecognized role in maintaining differentiated
hepatocyte function during chronic alcohol exposure. The overall hypothesis of this proposal is that
during alcohol exposure, KCs produce signals, such as exosomal Let-7, that help to maintain
hepatocytes in their differentiated state. Loss of KCs or KC function can trigger an AH-like loss of liver
function. Upon alcohol cessation, KCs are also required for resumption of liver homeostasis and fibrosis
resolution. Loss of KC subsets can delay recovery and suppress resolution of ALD fibrosis. In the
current proposal we will determine how specific KC and IM subsets regulate hepatocyte function during
alcohol exposure, how they change and function upon cessation of alcohol consumption, and how this
information can be used to improve liver function and enhance recovery from ALD. We will achieve
these goals with the following specific aims. (1) To determine the functions of KC and IM subsets in a
mouse model of ALD, (2) to determine how Kupffer cell loss promotes hepatocyte transition to a
progenitor-like state, and (3) to assess the role of MΦ subsets in fibrosis development and resolution
after alcohol cessation. Understanding the factors that regulate the presence and function of alcohol-
specific KC subsets would provide the opportunity to develop macrophage-based therapies to reverse
liver failure in patients with AH and accelerate recovery in patients with ALD who cease alcohol
consumption.

Public health relevance
PROJECT NARRATIVE Alcohol-associated liver disease is a major health problem accounts for approximately 40,000 deaths per year in the US. This project will examine the role that liver cells called Kupffer cells play in supporting and maintaining liver function during alcohol exposure. Understanding how alcohol specific Kupffer cells are able to protect the liver will allow development of therapies to reverse liver failure and accelerate recovery in patients who cease alcohol consumption.